Focal Adhesion Kinase - Tumor Biology and Therapeutics

PROJECT ABSTRACT
Focal Adhesion Kinase (FAK) is a multifunctional non-receptor tyrosine kinase and scaffolding protein that is
overexpressed in numerous solid tumors including melanoma, while minimally expressed in normal tissue. FAK
has been widely investigated as a cancer drug target due its contribution in multiple aspects of tumor progression,
including adhesion, invasion, proliferation, survival, metastasis, angiogenesis, and immune cell suppression.
However, development of FAK inhibitors has largely focused on inhibition of the kinase enzyme of FAK opposed
to inhibition of key scaffolding interactions. Particularly, limited efforts have been made at the discovery and
biological evaluation of inhibitors of the focal adhesion targeting (FAT) scaffolding domain of FAK, the domain
required for FAK localization to focal adhesions. During this period of support, we have identified the first
discovered stapled peptide-based FAK inhibitor (UA-1907) that binds to and co-crystallizes with the FAT domain,
and competitively inhibits FAK-paxillin binding. We have identified a myristoylated derivative (UA-2012) with
improved cellular potency, favorable drug-like properties, and in vivo efficacy; and developed a bivalent peptide
(UA-2023) with low nanomolar binding to FAT. However, the mechanistic differences between these novel FAT
domain peptides and traditional FAK-kinase inhibitors on perturbation of focal adhesion complexes and the FAK
interactome have yet to be elucidated. Furthermore, we have preliminary data showing that FAT inhibition
provides selective anti-cancer effects in NRAS mutant melanoma cells. Melanoma is the deadliest form of skin
cancer and there are no current effective targeted therapies against NRAS mutant melanoma, which represents
~30% of all patients. We hypothesize that FAK FAT domain inhibitors have distinct biological effects on
the focal adhesion complex in cancer cells compared to FAK kinase inhibitors; and cancer cells with
alterations in NRAS signaling pathways have a molecular dependence on FAK FAT scaffolding for
survival, thus promoting selective anti-cancer efficacy. In specific aim 1, we will identify the unique
differences between FAK FAT scaffold inhibitors and FAK kinase inhibitors on modulation of the focal adhesion
complex and the FAK interactome. In specific aim 2, we will define the molecular mechanisms of
sensitivity/resistance to FAK FAT inhibition in melanoma cells with activating mutations in NRAS and BRAF
pathways. In specific aim 3, we will evaluate in vivo efficacy of novel FAK FAT domain inhibitors in mouse models
of NRAS and BRAF driven cancer. Overall, in this project we will utilize FAT stapled peptides to validate that
FAT domain targeting provides additional biological efficacy on the focal adhesion complex compared to FAK-
kinase inhibitors and that NRAS mutant melanoma has a unique sensitivity to FAK FAT inhibition.
.

Public health relevance
PROJECT NARRATIVE This research will evaluate how a novel class of peptide-based inhibitors of the cancer protein focal adhesion kinase (FAK) blocks melanoma cell invasion and survival through disruption of the focal adhesion complex. It will utilize CRISPR-engineered melanoma cell models test the sensitivity of a specific subtype of melanoma (NRAS-mutant) to peptide inhibitors of FAK. Furthermore, it will utilize patient derived xenograft (PDX) mouse models of melanoma to validate FAK inhibitor efficacy in vivo.